Studying heterogeneity in [18F] FDG accumulation at the individual cell level using Betabox technology to better understand PET scans of patient tumors

PROJECT SUMMARY
[18F]FDG PET is a key imaging approach used regularly for the diagnosis, staging, and identification of
recurrences of various cancer types including lung, colorectal, and esophageal cancers. Studies have also
shown that decreases in tumor [18F]FDG accumulation can function as a biomarker of drug efficacy. [18F]FDG
PET is well-studied at the level of bulk cell populations, but studies of [18F]FDG accumulation at the level of
individual cells that could yield information on cell subpopulations are lacking. Studies of cancer cell genomes
and transcriptomes at the level of individual cells demonstrate important heterogeneity and subpopulations in
bulk cell populations. Similarly, the few available studies of [18F]FDG accumulation at the level of individual cells
suggest potentially important heterogeneity but this remains largely unexplored. Identifying subpopulations of
cells with differing levels of [18F]FDG accumulation could improve how we interpret pre-clinical and clinical
[18F]FDG PET scans at baseline and following treatment by, for example, identifying which subpopulation is the
main driver of [18F]FDG PET signal measured in bulk. We recently developed the BetaBox, a new technology
platform for measuring PET radiotracer accumulation at the individual cell level. Our preliminary data using the
BetaBox demonstrates heterogeneity in [18F]FDG accumulation in cancer cells as well as our ability to use the
BetaBox to measure [18F]FDG accumulation at the level of individual cells. However, prior research by our group
and others on [18F]FDG accumulation at the level of individual cells is limited to four cell lines and mostly involves
untreated cells in culture. Additionally, the current BetaBox is limited in the number of cells that can be studied
at any one time and has no mechanism for isolating and further studying potentially interesting cells. The goal of
this proposal is to use the BetaBox to study [18F]FDG accumulation at the level of individual cells across model
systems in culture and in vivo including cell lines, patient-derived sphere cultures, and patient-derived xenografts
with and without drug treatment, and to use this information to identify subpopulations of cells that differ in their
[18F]FDG accumulation for comparison across samples. An additional goal is to develop next generation BetaBox
technology to enable hundreds of cells to be studied simultaneously and for interesting cells to be isolated for
further functional characterization. We propose to accomplish this through the following three Specific Aims: (1)
To develop the next generation BetaBox to increase throughput and enable isolation of individual cells for further
analysis. (2) To characterize cell subpopulations based on [18F]FDG accumulation in individual cells across model
systems in culture and in vivo. (3) To study based on [18F]FDG accumulation in individual cells how cell
subpopulations change in response to targeted kinase inhibitors.

Public health relevance
PROJECT NARRATIVE [18F]FDG PET is used regularly to detect and stage cancers, and can be used as a pharmacodynamic biomarker of certain drugs. Although [18F]FDG accumulation in bulk cell populations is well-studied, much less is known about [18F]FDG accumulation at single cell resolution despite what is likely important heterogeneity. Here we propose to further improve the Betabox technology and to study [18F]FDG accumulation at single cell resolution using Betabox technology in cancer cells in culture, in mice, and in response to treatments with potential implications for how clinical [18F]FDG scans are interpreted.